Spatial Imaging Technology Resource

SpITR supports 5 technology platforms: 1) the SimpleWesternTM capillary nano-immunoassay (CNIA) system; 2) the bead-based Luminex xMAP multiplexed-immunoassay system for high-performance, quantitative protein measurement with small sample consumption; 3) the PhenoCycler (formerly known as the CODEX) technology for quantitative detection of 40-60 protein markers in tissues at single cell level; 4) GeoMx Digital Spatial Profiler (DSP) enabling detection of 100s of proteins and thousands of RNA targets including cancer transcriptome and whole transcriptome from a single tissue; and 5) CosMx Spatial Molecular Imager (SMI) to image expression of 1000 or 6000 of RNA transcripts or 64 proteins at single cell level in tissues. Currently the core evaluates multiple mid-plex immunofluorescent assays to remove the bottleneck in the spatial exploration of tumor/tissue microenvironment by running samples in parallel to increase throughput. 1) The SimpleWesternTM CNIA system is an automated capillary immunoassay system for highly quantitative, reproducible detection of target proteins and their post-translational modifications in a format that is applicable to very small sample sizes. The CNIA analysis platform fills a need for high-performance assays for comprehensive and quantitative signaling molecule profiling at the protein level and facilitates transferring those assays from discovery research into preclinical/clinical practice. SpITR is one of the earliest adopters of the CNIA technology. We established assay conditions for more than three hundred signaling molecules covering key pathways, including targets in apoptosis/cell death, cell cycle and checkpoint control, gene and RNA regulation, cell proliferation and development. Collaborating with CCR investigators, we have successfully developed protocols/strategies supporting multiple clinical trial and drug-development programs. In FY25, we worked with three PI/Research groups in support their projects and processed more than 100 samples. 2) The Luminex xMAP bead-based multiplex-immunoassay system provides a highly quantitative multiplex-analysis of cytokines, metabolites and other serum/plasma biomarkers. The technology has been broadly applied in life-science research including cancer, immunology, cardiovascular disease, metabolic disease, and inflammation with clinically applicable assay performance. Using this technology, we have been supporting projects on clinical and pre-clinical studies to monitor immune or other treatment responses in cancer therapies. In addition to full support for the technology, we also offer walk-up access to the instrument, so users do not need to sustain multiple individual instruments at high cost in their laboratories. This fiscal year, we have been working with 2 PIs on their research projects and had discussion with 2 other investigators for planning their studies processing more than 65 samples. 3) For the past five years, SpITR has offered the Phenocycler (CODEX) platform to CCR/NCI and NIH labs/branches. Phenocycler platform enables simultaneous quantification of 40-60 protein markers in tissue sections at single-cell resolution while preserving spatial context. This allows in-depth profiling of immune-tumor interactions, cellular neighborhoods, and treatment responses. As one of the most advanced Phenocycler sites, SpITR has led improvements in imaging, data processing, and analysis workflows and in 2023, upgraded one CODEX system to the Phenocycler-Fusion (PCF), the fastest commercially available multiplex-imaging system. The Core expanded assay coverage to include a wide range of fresh-frozen and FFPE human/mouse tissues (e.g., lung, liver, ovarian, breast cancers; melanoma; neurofibroma; lymphoid tissue). New developments include: implementation of FFPE and tissue microarray (TMA) protocols; integration of post-assay HandE staining to aid pathologist interpretation and custom antibody panel expansion (from 39 to 52 targets) to better characterize the tumor microenvironment. In this fiscal year, SpITR supported 10 PI/Research groups. To date, 8 manuscripts using this technology have been published, with 6 more in preparation. SpITR also collaborates with other CCR technology cores to build infrastructure for data storage, sharing, and analysis. 4) In partnership with the CCR Genomics Core, SpITR provides access to the GeoMx DSP platform, which combines immunofluorescence with nCounter or NGS readouts to enable high-plex spatial profiling of both RNA and proteins in tissue sections. Available panels include the 1,800-target Cancer Transcriptome Atlas (CTA) and the 18,000-target Whole Transcriptome Atlas (WTA). SpITR's unique contribution involves customizing morphology markers to improve region-of-interest (ROI) selection and support full-slide analysis, extending the platform's utility. In FY 25, SpITR supported 10 investigators with cancer discovery and clinical specimen profiling. This work has contributed to two published manuscripts and five more in preparation. 5) Since September 2022, with support from OSTR, SpITR has led the implementation of the CosMx SMI platform. CosMx offers single-cell resolution for RNA (1,000-6,000 targets) and protein (64 targets) detection, complementing GeoMx and CODEX technologies. Initial projects on liver and colon cancer have been completed, with one manuscript submitted and others in progress. Demand for CosMx is growing rapidly, fueled by positive results and increased interest from the research community.